2022 Plasminogen Activation and Extracellular Proteolysis Gordon Research Conference and Seminar

Summary
Partial support is requested for graduate students and post-doctoral fellows, and junior and midcareer faculty
to participate in the Gordon Research Seminar and Conference (GRS/GRC) entitled “Plasminogen Activation
and Extracellular proteolysis”, which will be held in Ventura, CA on February 5-6 and 6-11, 2022, respectively.
This will be the 18th GRC, as the conference has been held continuously every two years since 1990. The
focus of the 2022 GRC will be on mechanisms and therapeutic targets of extracellular proteolytic enzymes,
including plasmin(ogen), plasminogen activators, coagulation proteases, matrix-metalloproteinases (MMPs),
their precursors, inhibitors, and effectors. Recent data suggest that the expression of proteases in circulation
and the extravascular compartments of tissues is tied to numerous pathological processes. Our invited
speakers and discussion leaders will present their recent and emerging work across a spectrum of basic
science and clinical topics, including cardiovascular disease, aging, cerebrovascular function, metabolic
diseases, musculoskeletal and neurodegenerative diseases, cancer, infection and immunity, tissue remodeling
and regeneration, as well as trauma. Priority will be placed on highlighting both the role these proteins play as
disease modifiers as well the utility of employing or targeting these factors for diagnosis and therapy. One of
the major goals for the 2022 GRC meeting is translating basic research into the clinic. Attendees will be
selected by invitation and from applications submitted online. They will be chosen to represent a diverse
spectrum of research, with a strong emphasis on equity of opportunity and inclusion of individuals across all
demographic metrics. Additional efforts will be committed to recruit women and scientists of underrepresented
groups as session leaders and speakers for both the GRS and GRC. Indeed, an intended strength of this
meeting will be the interaction and networking of the young scientists in the field, with the discussion leaders
and the speakers. The associated GRS, which is a younger feature of the conference, will provide a unique
opportunity for trainees and beginning scientists to present their research and share the GRC experience. This
two-day seminar will be organized by Graduate Students and Postdoctoral Fellows with the support of leading
researchers and the GRC Chairs, and will allow junior researchers within the field of plasminogen activation
and extracellular proteolysis to come together to discuss their current unpublished research, while building
informal networks with their peers that may lead to a lifetime of collaboration and scientific achievement.

Public health relevance
Narrative Plasminogen activation and extracellular proteolysis are rapidly advancing research areas as they intersect with basic science and clinical research. Critical roles for extracellular proteases are identified in many disorders related to cardiovascular disease, stroke and other neurological disorders, cancer, musculoskeletal and infectious diseases, as well as infection. It is increasingly evident that research in this area is critical for the development of novel strategies and agents to treat these diseases.